Systematic identification and characterization of immunogenic double-stranded RNAs

PROJECT SUMMARY AND ABSTRACT:
Cellular innate immune receptors play a vital role in recognizing pathogenic molecules and initiating an innate
immune response to combat infections. However, when these receptors mistakenly sense "self" molecules, it
can lead to the development of autoimmune diseases. One such cytosolic receptor, MDA5, forms filaments on
viral double-stranded RNA (dsRNA) to activate the antiviral interferon (IFN) signaling pathway. The question
arises: how does MDA5 differentiate between "self" cellular dsRNAs and "non-self" viral RNAs? Research con-
ducted by our team and others suggests that the ADAR1 protein catalyzes Adenosine-to-Inosine (A-to-I) RNA
editing on cellular dsRNAs, marking them as "self" RNAs and preventing erroneous MDA5 sensing. Mouse mod-
els deficient in ADAR1 RNA editing are not viable, but their survival to the full lifespan can be rescued by remov-
ing MDA5. In humans, rare autoimmune diseases such as Aicardi-Goutieres Syndrome exhibit loss-of-function
mutations in ADAR1 and gain-of-function mutations in MDA5. Our recent work has shown that insufficient editing
of dsRNAs is associated with presumed dsRNA-mediated inflammation in various autoimmune and inflammatory
diseases, including Inflammatory Bowel Disease, Multiple Sclerosis, Parkinson's Disease, and Coronary Artery
Disease. In the well-established ADAR1-dsRNA-MDA5 axis, there is an urgent need to identify the specific cel-
lular dsRNAs that require ADAR1 editing to evade MDA5 sensing. We define these dsRNAs as immunogenic
dsRNAs, as their lack of editing leads to increased immunogenicity.
The primary objective of this research is to develop effective approaches to systematically identify and charac-
terize immunogenic dsRNAs involved in inflammatory diseases and to investigate how the editing status and
expression level of dsRNAs influence their immunogenicity. Firstly, we will utilize a recently developed genetic
approach to identify immunogenic dsRNAs in various human cell types that we determine to be most relevant in
inflammatory diseases. Subsequently, we will employ genetic, biochemical, and computational methods to thor-
oughly characterize and validate these immunogenic dsRNAs. Secondly, we will expand our work on systemat-
ically identifying genetic variants associated with editing levels. This expansion will enable us to pinpoint immu-
nogenic dsRNAs that colocalize with GWAS loci associated with common autoimmune and inflammatory dis-
eases. Additionally, we will develop a predictive model to assess an individual's burden of immunogenic dsRNAs
as a cumulative measure. This model will aid in stratifying patients with inflammatory diseases, where impaired
dsRNA editing and heightened dsRNA sensing likely contribute to chronic inflammation. In summary, by identi-
fying the most crucial dsRNA substrates of ADAR1 and ligands of MDA5, this work will bridge a significant
knowledge gap in the field. Furthermore, it will provide important mechanistic insights and therapeutic potential
regarding how ADAR1 RNA editing prevents MDA5-mediated dsRNA sensing and innate immunity in both
healthy and inflammatory disease contexts.

Public health relevance
PROJECT NARRATIVE: RNA editing plays a crucial role in cellular processes to prevent autoimmunity, making aberrant RNA editing a significant factor in the development of autoinflammatory diseases. We aim to employ advanced experimental and computational techniques to identify critical RNA substrates in autoinflammatory diseases. By integrating these substrates into a cumulative score, we seek to enable the stratification and treatment of patients with diverse autoinflammatory conditions.